Prevalence, etiology, and clinical implications of low count monoclonal B-cell lymphocytosis (MBL)

Monoclonal B-cell lymphocytosis (MBL) is one of the most common malignant precursor conditions, affecting
8-10 million adults >40 years of age in the United States. MBL is defined by the presence of a clonal B-cell
population in the blood with sub-classification based on the immunophenotype of the cell surface markers and
the size of the B-cell clone: low-count MBL (LCMBL) is defined as clonal B-cell count <0.5 x109 cells/L and
high-count MBL (HCMBL) as clonal B-cell count between 0.5 and 5x109/L. Of clinical and

Public health relevance
Project Relevance to Public Health: Monoclonal B-cell lymphocytosis (MBL) is one of the most common malignant precursor conditions, affecting 8-10 million adults over the age of 40 years in the United States. Our work indicates that the presence of MBL, in particular low-count MBL (LCMBL), is a biomarker for adverse clinical outcomes. This application proposes to build on our prior work to expand our knowledge of the etiology and clinical outcomes of LCMBL.